The Administrative Core

SUMMARY - ADMINISTRATIVE CORE (CORE C)
The overall goal of this PPG is to elucidate the molecular mechanisms of HCMV regulation of cellular signaling
in the establishment and maintenance of viral latency and viral reactivation. To meet this goal, we have
assembled an extraordinary group of virologists who will collaborate in five highly interactive projects and two
scientific cores. The Program Director (PD) and Principal Investigator of the Administrative Core is Jay Nelson,
Ph.D., who is a senior molecular virologist with extensive experience studying the molecular interaction of
cytomegaloviruses and their host environment. Dr. Nelson will be co-leading this program with Dr. Andrew
Yurochko, who is an international expert in the study of Human Cytomegalovirus dissemination and
pathogenesis. They will be assisted by an exceptional administrative team that has a proven track record in
administering and managing large, complex grants and contracts such as the Pacific Northwest Regional
Center of Excellence in Biodefense and Emerging Infectious Diseases (PNWRCE), two NIAID Adjuvant
Discovery Contracts, and the ongoing original P01 on which this renewal proposal is built upon. The significant
experience of this group with the organization, reporting and communications associated with the successful
administration of multi-institutional research programs will be invaluable in ensuring a successful management
of this PPG. The Administrative Core will serve as a hub for administration, communication and monitoring for
the entire program. The core will serve all projects and all scientific cores, and it will interact with all institutions
involved in this program. The Administrative Core will also serve as a central point of interaction with NIH
Program. Finally, the administrative team will assist the program director in ensuring regular and timely
communication among the members of this consortium as well as reporting to NIAID program.